Dissecting Causal Role of Insomnia in Cardiovascular Disease

Alzheimer’s disease (AD) is a leading public health problem. One of the many physiologic processes affected by
AD is the circadian system, with disruption reflected in abnormalities of the sleep-wake cycle. While sleep and
circadian rhythm defects are distressing symptoms of AD and other tauopathies, sleep disturbance may be a
major risk factor for AD and is also thought to accelerate its pathology. Early in AD, disruption of circadian cycles,
including sleep, is thought to contribute to the accumulation of amyloid, and subsequent cognitive decline.
Current sleep-promoting treatments for insomnia in AD may have different efficacy and adverse effect profiles.
We propose the following Specific Aims: 1) To test if use of sleep medication associates with improved sleep
patterns and altered cognitive and cardiac outcomes in patients with high genetic risk of AD. We will leverage
the UK Biobank to examine the links between sleep medications, sleep, cognitive function and heart health in
people at high genetic risk for AD using prospective associations and novel mendelian randomization techniques
designed to test the effects of perturbing drug targets. 2) To test sleep-promoting agents used to combat
insomnia in AD patients in Drosophila models of AD for adverse effects on cognitive and cardiac health. We will
also test novel therapeutics for potential use in individuals with AD with sundowning syndrome for their ability to
ameliorate circadian phenotypes in Drosophila tauopathy models. 3) To test prevention of Tau aggregation using
a novel proximity-directed O-GlcNAcylation strategy. Hyperphosphorylation of Tau is a major driver of self-
assembled protein aggregation, which can be competed by O-GlcNAcylation. We will use nanobodies fused to
OGT to direct O-GlcNAcylation to Tau and test amelioration of the effects of Tau-dependent neurodegeneration
in vivo using Drosophila tauopathy models. Together these studies will help improve our understanding of sleep
medications for treatment of AD, as well as help devise and test new therapeutic approaches.

Public health relevance
Sleep and circadian rhythm defects are distressing symptoms of Alzheimer’s Disease (AD), as well as being a major risk factor and accelerate its pathology. We will investigate whether sleep medication associates with improved sleep patterns and altered cognitive and cardiac outcomes in patients with high genetic risk of AD, test sleep-promoting agents for adverse effects on cognitive and cardiac health in Drosophila models and test a novel proximity-directed O-GlcNAcylation therapeutic strategy to prevent Tau aggregation. These studies will help improve our understanding of sleep medications for treatment of AD, as well as help devise and test new therapeutic approaches.